Identifying Intrinsic Regulators of Areal Patterning in The Neocortex by Single-Cell RNA-seq and Organoid Arealization

Identifying Intrinsic Regulators Of Areal Patterning In The Neocortex by Single-Cell RNAseq And Organoid Arealization Project Summary/Abstract The mature human neocortex (Ncx) is an incredibly complex structure, which is organized into functionally specialized areas, unique in their cytoarchitecture and connectivity patterns to the rest of the brain. Cortical areas are selectively dedicated to distinct processes, ranging from cognition and sensory perception to motor output. All neocortical excitatory neurons (ExNs) arise from a common progenitor pool of radial glia (RG), the neural stem cells of the Ncx, and their transit-amplifying intermediate progenitor cells (IPCs). Newborn ExNs then migrate to the cortical plate along the RG scaffold, in a process conserved across prospective areas. However, the mature Ncx is a mosaic of ExN populations. It is currently accepted that Ncx arealization is the result of a combination of intrinsic genetic mechanisms, including transcription factors (TFs) differentially expressed by progenitors, and of extrinsic influences, primarily in the form of thalamocortical input. The relative contribution of these two components, however, is not well understood. Over the past 30 years, seminal studies have uncovered molecular differences across cortical areas, as well as genes crucial for areal specification, but still there remains much to be explained. Recent advances in single-cell sequencing have begun to illuminate additional cell type diversity that exists in mouse and human brains, with significant transcriptional areal differences between otherwise corresponding ExN subtypes. Understanding how these differences emerge is essential to understanding how neurodevelopmental disorders may arise, as well as to more accurately model human cortical cell types and understand how stem cell therapies may best be developed in an area specific manner. A systematic characterization of RG and ExNs across areas of the developing Ncx is a powerful approach to study intrinsic arealization factors. To this end, we have previously generated a spatially-annotated dataset of ~550,000 single-cell transcriptome profiles from distinct areal subdissections of the Ncx during the period of peak neurogenesis. My analysis will focus on identifying molecular subtypes of RG and ExNs specific to prospective areas of the developing Ncx, and determining their unique genetic markers and expression signatures, with a particular emphasis on TFs. Using cortical organoids, I will evaluate the capacity previously described key arealization genes to drive spatial identity in a human context. Building on this system, I will evaluate the functional importance for arealization of 2 TFs identified in my preliminary analyses as being preferentially expressed by RG of frontal and occipital Ncx, respectively. Through this work, I aim to further shed light on the intrinsic mechanisms that shape diversity across areas of the human neocortex.

Public health relevance
Identifying Intrinsic Regulators Of Areal Patterning In The Neocortex by Single-Cell RNA-seq And Organoid Arealization Project Narrative Understanding the heterogeneity of cell types that exist during human cortical development is fundamental to elucidating how they give rise to the complex, areally specified adult cortex, and how they may contribute to neurodevelopmental disease. Recent studies leveraging single-cell transcriptomic profiling have described previously unknown variation and novel cell types in the developing cortex, and I seek to explore the role of this molecular heterogeneity among neural stem cells and newborn neurons in the specification of distinct cortical areas. A better understanding of the intrinsic mechanisms of cortical arealization will offer new perspectives into neurological and neuropsychiatric diseases preferentially affecting specific cortical areas, and in turn, can pave the way for more effective stem cell therapies that more accurately target the cell type and area of interest.